Integrated Training in Anesthesiology Research

The goal of this program is to provide postdoctoral fellows with research training enabling them to develop independent investigative careers devoted to improving care of the anesthetized/critically ill/chronic pain patient by advancing scientific knowledge in the field. The Department of Anesthesiology at Duke University Medical Center has intensively invested its resources in the development of multidisciplinary laboratory and clinical research environments to offer state-of-the-art research training experiences. We have also innovated in anesthesiology residency training to provide an enhanced research experience and enabling a continuum toward a highly effective preparatory phase prior to T32 enrollment. This proposal outlines the credentials of a distinguished training faculty who are willing and prepared to meet our goal. The training program involves a 2-3-year continuum when the trainees work under the close and direct supervision of a faculty member on research projects of mutual interest. Emphasis is placed on learning responsible research skills, achieving mastery of the literature, independent hypothesis generation, experimental design, data analysis, presentation and publication of research findings, and competition for extramural funding. All trainees are encouraged to utilize relationships established with members of the program faculty for both enrichment of research skill repertoires and development of long-term collaborative relationships. The program is overseen by the program director and co-director and an oversight committee consisting of senior scientists along with the departmental chair. Trainees formally report to the program leadership at quarterly intervals to allow assessment of training performance and progress in achieving program goals. Trainees are sought from a national pool of eligible candidates. The primary focus of this program is the research training of four select post-doctoral fellows, with the goal of transitioning to junior faculty positions and pursue their scientific endeavors in an academic environment. However, the program is also the cornerstone of our departmental research training endeavor setting high standards for investigative training offered to medical students, residents, junior faculty, and visiting scholars who participate in the research training process.

Public health relevance
This program is designed to provide intensive training and research relevant to patients requiring anesthesia, critical care, and/or pain interventions. Provision of the next generation of physician-scientists will serve to improve medical care based on acquisition of scientific evidence and better understanding of relevant disease states.